The Role of Rx in the Adult Retina

Rx is expressed in mouse embryos at E7.5 in the presumptive forebrain and becomes restricted to the developing retina, posterior pituitary and hypothalamus. Deletion of the Rx gene revealed that it is required for the formation of these structures, as its loss causes anophthalmia and ventral neural tube defects. Recently, Rx has also been shown to be active in the adult mouse and human neural retina (V. Voronina and P. Mathers, unpublished). To determine the role of Rx in adult retina physiology, we are performing conditional knockouts of the gene after retinogenesis is complete. To achieve this, we have produced mice that carry a floxed Rx gene so that normal Rx function can be disrupted by Cre-mediated recombination. We are using two independent approaches to specifically target Cre-recombination to floxed-Rx mice. The first will induce Cre expression in the retina (and elsewhere) of adult mice using a cre transgene that is inducible by tamoxifen. This global expression should only affect the retina, as Rx is not expressed in other adult tissues. In the second approach, we are specifically deleting Rx in a subset of retinal cells by using various retinal-specific transgenic Cre mice. These two strategies for the deletion of adult Rx gene function will provide a model for two common causes of blindness, retinal dystrophy and retinal degeneration.